The Effect of Visual Stimuli on Sound Representation in the Macaque Inferior Colliculus

PROJECT SUMMARY/ABSTRACT:
Visual cues can help the brain localize sounds. At the neural level, the brain might accomplish this by altering
its response to sounds in the presence of visual signals. This could occur for single sounds, allowing the brain
to use visual information to guide sound localization. This could also occur for multiple sounds, allowing the
brain to connect visual information to the appropriate sound in a noisy environment.
To test these possibilities, two rhesus macaques will perform a task in which they will localize one or two
sounds in the presence or absence of accompanying lights. While the monkeys perform this task, we will
record from single and multiple neurons in the inferior colliculus (IC), a critical auditory region that receives
visual input and has visual and eye movement-related responses. To test whether visual cues alter the
representation of single sounds, monkeys will localize a sound, light, or sound-light pair at a shared location.
We expect that IC neurons will have a different response to sounds than to sound-light pairs. To test whether
visual cues alter the time-varying response to multiple sounds, monkeys will detect two simultaneous sounds,
each of which dominates the response of the neuron during distinct periods of time. We will compare IC
neurons’ responses to two sounds, two sounds with one paired to a light, and two sounds with both paired to a
light. When one sound is paired to a light, we predict that IC activity will skew toward the visually-paired sound.
These experiments will help clarify the influence of visual cues on auditory responses and will provide insight
into how the brain combines visual and auditory information into a single perceptual object.
In addition to the proposed research, a training plan will also be carried out at Duke University, an environment
offering many resources for both academic and professional development. The fellowship training plan takes
advantage of opportunities both at Duke and in the community to support preparation for a research career
with an emphasis on science communication. The proposed research will also facilitate professional
development through the advancement of technical, analytical, and communication skills.

Public health relevance
PROJECT NARRATIVE: This project investigates how the brain integrates visual and auditory information. Deficits in this ability contribute to poor communication performance in noisy scenes in central auditory processing disorder and age-related hearing loss. Insights from these experiments could ultimately lead to improvements in the treatment of these and related conditions.